Transcriptional regulation of T cell immunity

Summary
Infectious diseases, including Hepatitis C (HCV) and HIV, remain important health problems among Veterans.
Development of vaccines for infectious diseases is therefore a key priority. Immunologic memory is a cardinal
feature of adaptive immunity and an important goal of vaccination strategies. Traditional vaccination strategies
are very effective at generating neutralizing antibodies, but not effective T cell memory. A key reason for the
current lack of effective vaccines against many infectious diseases is that we do not yet know how to make
vaccines that generate robust T cell memory. Thus, a fundamental understanding of how memory cells are
formed is a crucial first step in rational vaccine design for infectious diseases.

Public health relevance
Complications from chronic infectious diseases contribute to significant morbidity and mortality in the Veteran population. Effector and memory T lymphocytes are cells of the immune system that provide protection against infections. Our goal is to understand how these cells are generated and how they function in response to different infections. These studies may help our efforts to improve vaccines.